Action of psychostimulant drugs on neuronal intrinsic excitability and drug-seeking behavior

Drug addiction is a chronic psychiatric disorder that imposes a huge burden on the lives of addicted individuals,
their families and society as a whole. Importantly, a significant proportion of addicts remain resistant to
treatment. Diversifying pharmacotherapies that target mechanisms beyond canonical mechanisms of addiction
involving dopamine (DA) and monoamine signaling could address this gap. Here we propose to study a novel
and long-lasting neuroadaptation to chronic cocaine that is mediated by a non-canonical, DA-independent
mechanism. Chronic cocaine induces a persistent decrease in the intrinsic excitability (firing rate) of nucleus
accumbens shell (NAcSh) neurons. This adaptation is mediated by the sigma-1 protein (σ1; a.k.a. Sig-1R), a
chaperone whose activity is regulated by synthetic and endogenous molecules in a clear agonist-antagonist
manner. Cocaine is an agonist of σ1, and our accumulating evidence suggests that cocaine activation of σ1
enhances the formation of σ1-Kv1.2 protein complexes, their subsequent accumulation at the plasma
membrane, thereby decreasing intrinsic excitability of NAcSh neurons. This mechanism is not unique to
cocaine, and is induced by other psychostimulant drugs including methamphetamine, suggesting a common
mechanism contributing to psychostimulant addiction. Our previous study showed that either pharmacological
blockade or NAcSh-specific knockdown of σ1 prevents the development of enhanced Kv1.2 currents and
reduced excitability while attenuating psychomotor sensitization to cocaine—a process that may contribute to
the development of addiction. Moreover, NAcSh-specific overexpression of Kv1.2 subunits, which mimics
cocaine-induced neuronal hypoactivity, amplifies sensitization to cocaine. We hypothesize that
psychostimulant drugs act through a common DA-independent pathway that leads to σ1-dependent
upregulation of Kv1.2 in NAcSh MSNs to promote addiction, in addition to DA-dependent signaling effects.
Using cocaine self-administration (SA) procedures in mice, this research will determine whether the formation
of σ1-Kv1.2 protein complexes and firing rate depression is associated with the incubation of cocaine craving
after prolonged abstinence from cocaine SA (Aim 1). This research also will employ: (i) a combination of
molecular approaches only available in cell culture models including multiphoton confocal cell imaging to track
Kv1.2 trafficking following in vitro cocaine exposure, and (ii) a pharmacological approach targeting key
endocytic/recycling machinery to validate a similar approach in NAcSh slices (Aim 2). To provide behavioral
relevance to this novel mechanism of cocaine action, we will determine how NAcSh-specific σ1 and Kv1.2
modulations during cocaine SA alter subsequent stages of the addiction cycle, including drug seeking after
withdrawal (Aim 3). Together, our work will provide a multipronged functional investigation of this mechanism
of drug addiction, from intracellular signaling to cell firing and relevant measures of addictive behavior. These
studies could pave the way for new and complementary pharmacotherapies to combat psychostimulant abuse.

Public health relevance
Drug addiction is a severe brain disease thought to originate from supraphysiological enhancement of dopamine neurotransmission in the brain. However, we have discovered that psychostimulant drugs also trigger a common non-canonical, dopamine-independent mechanism that involves the endoplasmic reticulum chaperone protein sigma-1, thereby leading to nucleus accumbens neuronal hypoactivity. The goal of this project is to extend this novel finding by determining: 1) its longevity after cocaine self-administration; 2) the cellular basis of this novel mechanism; and 3) its contribution to cocaine-seeking behavior.